Administrative Core

Abstract
The primary goal of the Administrative Core (Core C) is to support and promote the program and data
management goals of this TBRU. Amongst its responsibilities, Core C will provide leadership that ensures
strong oversight and representation of all the Core and Affiliate Researchers in decisions, facilitate integration
of research projects, and connect with other TB Research Units and the broader infectious disease community.
We will form an internal Program Leadership Team (PLT) consisting of the Co-Investigators, who will regularly
evaluate progress of the Projects and Cores. We will identify needs as they arise, as well as review and
possibly modify priorities and research directions. We will implement these efforts with two Aims in Program
Management and Data Management. The Program Management plan includes administrative structure and
governance, communication, financial management, regulatory compliance, and evaluation. The Core C Data
Management Plan will guide management of data across all study sites. A vital activity of Core C will be to
facilitate communication amongst the TBRU members located around the world and with the other members of
the community and will organize and manage a number of regularly scheduled meetings, some specifically for
members of the PLT and others for the entire research team. These various meetings will provide important
opportunities to share and discuss overall research directions and specific experimental concerns. The Core
will plan yearly workshops which will feature talks by all TBRU faculty members as well as presentations from
other members of the infectious disease community. Core C will lead the maintenance of the TBRU Center
website and shared file servers. To provide formal site review and involvement with NIH, the Core will organize
an annual External Scientific Advisory Group Meeting, in which the MPIs and key personnel will meet with NIH
program staff to review activities. Overall, the Administrative Core will ensure that projects are productive,
synergistic and have sufficient support and resources to flourish.